Harnessing human gut-derived Bacteroides to drive systemic anti-tumor immunity

Although immune checkpoint blockade has transformed therapeutic options for lung cancer, its efficacy
differs widely even between patients with remarkably similar disease, and while few have lifelong remissions,
the majority relapse after several months. Numerous clinical studies and pre-clinical mouse models have
demonstrated that certain compositions of mammalian gut microbiota (harboring particular bacteria) as well as
certain largescale manipulations (such as fecal transplant) can provide dramatic anti-tumor immunity in tissues
far removed from the intestine. As researchers heed this phenomenon, there are continued reports of various
“efficacious” bacteria. However, the mechanism by which any one of these gut-restricted commensals is able
to elicit an immune response in a distant tumor remains unknown. We do not appreciate in which anatomy the
host immune system is first provoked by the microbiota—is it locally within the mucosa, within the tumor
microenvironment itself, the draining lymph node, or elsewhere? We also do not know whether the microbiota
directly re-program cytotoxic T cells, whether they indirectly improve antigen presentation, or whether any
number of cells that participate upstream of the anti-tumor response are the first to be triggered.
We have set up a reductionist model in our preliminary work to clarify this, wherein gut colonization with a
commensal Bacteroides leads to striking anti-tumor responses in immunogenic lung tumor implants. The
phenotype is T cell-dependent, and it is strong enough to persist even in the absence of exogenous
immunotherapy. We also find a closely related but distinct Bacteroides species, which is capable of similarly
colonizing the gut; however, it does not render any anti-tumor effect, and so it serves as a control comparator.
Furthermore, bioengineering collaborators have established a “next-generation parabiosis” system, such
that mice housed in separate cages can each have their vasculature cannulated, and microfluidics can
continuously exchange blood flow. Remarkably, we find that a tumor-bearing mouse lacking gut colonization
will exhibit anti-tumor efficacy once it exchanges blood with a colonized mouse. Therefore, we wish to ask:
through which blood-borne component is efficacy transferred, and which host cell is first triggered?
The applicant, Dr. Rabi Upadhyay, an Assistant Professor in the Department of Medicine and the
Perlmutter Cancer Center at NYU Grossman School of Medicine, has outlined a 5-year career plan that builds
on his scientific background in immunology and microbiology as well as his clinical training in medical oncology
and immunotherapy. Dr. Upadhyay will conduct the proposed research under the mentorship of Dr. Dan
Littman, an internationally recognized expert in T cell immunology with a strong track record of training
successful physician scientists. Dr. Littman’s laboratory and NYU Perlmutter Cancer Center provides the ideal
institutional environment for Dr. Upadhyay to embark on the proposed research program, and transition to a
position as an independent academic investigator with his own laboratory and eventual R01 funding.

Public health relevance
Project Narrative This research will further our understanding of certain common bacteria which reside within our intestines throughout our lifetime, and how some of these bugs in particular can make our immune system more aggressive. By researching the way these bacteria “communicate” to our immune system, it may be feasible to pick the correct ones to package together as a probiotic. Such a medication could help cancer patients who want their immune system to behave aggressively against their growing tumor.